Methods for Mapping Genetic Regulatory Elements in Single Cells and Single Molecules

PROJECT SUMMARY
The human genome is regulated through interactions between DNA and proteins in the nucleus that define and
maintain the epigenetic state of cells. Therefore, large consortia such as the Encyclopedia of DNA Elements
(ENCODE) are dedicated to comprehensively mapping regulatory elements such as transcription factor binding
or histone modification so that we may understand regulatory processes that guide development, disease, and
the everyday functioning of cells in our body. However, current methods for genome-wide measurement of
protein-DNA interactions are unable to map regulatory elements in highly repetitive regions of the genome
because they rely on high-throughput, short-read DNA sequencing platforms. This limitation prohibits
comprehensive investigation of roughly 8% of the human genome including centromeres and ribosomal DNA
arrays, which play essential roles in chromosome segregation and nuclear organization. Furthermore, these
methods typically lack the sensitivity to profile the epigenetic landscape of single cells, preventing high-resolution
measurements of regulatory variation in complex tissues. The goal of this research program is to expand the
toolbox for mapping protein-DNA interactions genome-wide and extend capabilities to long-read sequencing and
single-cell sequencing technologies with the development of two methods: (1) Directed methylation and long-
read sequencing (DiMeLo-Seq) and (2) single-cell directed methylation and sequencing (scDiMe-Seq). To record
the genomic position of protein binding or histone modification, a methyltransferase fused to protein A will be
directed to the targeted regulatory element with a primary antibody. Upon activation, the methyltransferase will
methylate adenines in proximal DNA sequences. DiMeLo-Seq will implement long-read DNA sequencing
technologies such as nanopore sequencing to directly detect the position of these modifications on long
molecules of DNA, taking advantage of the differential signal generated by methyl-adenines as they pass through
the nanopore. This approach will produce sequencing reads of up to hundreds of kilobases long, providing high-
confidence mapping of regulatory elements to regions of the genome that are unmappable with short-read
sequencing. To detect these modifications with single-cell sensitivity, scDiMe-Seq will enrich genomic loci
containing methyl adenines through targeted digestion, adapter ligation, and PCR amplification. These enriched
fragments will then be sequenced using standard high-throughput sequencing. This project aims to develop
DiMeLo-Seq and scDiMe-Seq through rigorous protocol optimization of the directed methylation strategy and
sequencing library preparation for long and short-read sequencing. The methods will then be characterized and
validated by targeting well studied features such as lamina associated domains, and CTCF landscapes, as well
as H3K9me3 and CENPA which are both enriched in centromeres. The overall goal of this project is to produce
two robust and scalable methods that may shed light on regulatory mechanism in previously unexplored regions
of the genome and aid in Human Cell Atlas initiatives by providing epigenetic information for single-cell analysis.

Public health relevance
PROJECT NARATIVE The human genome is epigenetically regulated through protein-DNA interactions, histone modifications, and DNA methylation. However, current methods for measuring these regulatory elements, cannot map the epigenetic landscape in the ~8% of the genome that contains highly-repetitive sequences, nor do they have the sensitivity to measure epigenetic variation between single cells. The goal of this research program is to develop new tools for mapping protein-DNA interactions in long single molecules and in single cells, allowing complete profiling of epigenetic regulation in the human genome from telomere to telomere and with enough sensitivity to shed light on cell-to-cell epigenetic variability in developing or diseased tissues.